Viral dynamics of rebound and control following early treatment of HIV/SIV

ABSTRACT The striking identification of select patients who were able to durably control HIV rebound after ART discontinuation in the ANRS Visconti cohort, or in cases such as the Mississippi baby, have highlighted the possibility of sustained HIV remission and provided the first proof of concept that HIV remission may be clinically achievable. In several of these cases, post-treatment control is characterized by the very low, but detectable presence of HIV infected cells implying that in at least some cases of viral remission, a balance may have been struck between HIV-1 and the host. The mechanism(s) by which these reservoirs are subject to sustained virologic remission or ultimately rebound, upon ART interruption is not understood. Moreover, there is no validated biomarker that can predict clinical outcome during a treatment interruption. Therefore, a detailed understanding of the factors that dictate HIV suppression or relapse, in the absence of antiretroviral therapy, is critical to develop approaches to therapeutically foster HIV-1 remission in ART-treated patients. Thus, we propose detailed studies to define the impact of early antiretroviral therapy on virologic and immunologic outcomes that are relevant to achieving HIV remission and durable virus control after the cessation of ART. These studies encompass multi-disciplinary collaborations, to have the greatest breadth of investigation, and ultimately the greatest scientific impact. Our proposed investigations include analytic studies in both HIV-infected adult and pediatric patients. We will also conduct parallel studies in non- human primates, including the pre-clinical evaluation of novel eradication therapeutics.

Public health relevance
Although HIV-1 can be effectively suppressed with antiretroviral therapy, it is not eradicated from the body. The majority of HIV-1 infected persons who cease therapy have rapid viremic relapse due to the presence of long- lived HIV-1 reservoirs. The mechanism(s) by which these reservoirs are seeded, maintained, and are subject to sustained virologic remission or ultimately rebound, upon interuption of antiretroviral therapy is not understood. A detailed understanding of the factors that dictate HIV suppression or rebound, in the absence of antiretroviral therapy, is critical to develop approaches to therapeutically foster HIV-1 remission in patients on long-term antiretroviral therapy. Thus, we propose detailed studies to define the impact of early antiretroviral therapy on virologic and immunologic outcomes that are relevant to achieving HIV remission and durable virus control after the interuption of such therapy. These studies encompass multi-disciplinary collaborations, to have the greatest breadth of investigation, and ultimately the greatest scientific impact. Our proposed investigations include analytic studies in both HIV-infected adult and pediatric patients. We will also conduct parallel studies in non-human primates, including the pre-clinical evaluation of novel eradication therapeutics.